Career Enhancement Program

CAREER ENHANCEMENT PROGRAM: SUMMARY
The Northwestern Brain Tumor SPORE (NBTS) Career Enhancement Program (CEP) is responsible for recruitment and training of new and early-stage investigators committed to neuro-oncology research to ensure that there will be a continuous source of talented investigators committed to this field. The fact that the faculty mentors come from a variety of departments and disciplines provides robust and extensive scientific expertise to program awardees. CEP recipients are selected after wide solicitation of the request for applications and careful review of applicants’ credentials and potential to develop an independent career in brain tumor research. The CEP has flexibility in terms of offering awards and the length of the award. However, there is a consistent and highly structured process for solicitation and selection of CEP investigators and a detailed tracking system for monitoring their progress.

Public health relevance
CAREER ENHANCEMENT PROGRAM: PROJECT NARRATIVE The Career Enhancement Program is a critical component of the Northwestern Brain Tumor SPORE, in that it ensures that there will be a continuous influx of talented investigators devoted to brain cancer research.